Role of Myeloid Cell Lrp1 in Rift Valley Fever Virus Infection and Dissemination

PROJECT SUMMARY/ABSTRACT
Rift Valley fever virus (RVFV) is an emerging arboviral pathogen that can cause hepatic disease, hemorrhagic
fever, ocular disease, encephalitis, and teratogenic effects. This virus is endemic in Africa and the Saudi Arabian
Peninsula and competent mosquito vectors are also present in the Americas. The significance of this virus is
further evidenced by its status as an NIAID Category A pathogen and inclusion on the WHO’s Blueprint of Priority
Diseases. RVFV can infect macrophage and dendritic cells, and it is hypothesized that this is the mechanism by
which RVFV disseminates throughout the body following a subcutaneous infection. Yet, this has not yet been
validated in vivo. Following a footpad injection mimicking a mosquito bite, most inbred mouse strains succumb
to hepatic disease 3 – 5 days post-infection, which has made the study of RVFV dissemination difficult. Low-
density lipoprotein receptor-related protein 1 (Lrp1) was identified by our lab as a host entry factor for RVFV.
This protein is expressed across species and cell types permissive to RVFV. Lrp1 is an important signaling
molecule involved immune responses, but the role of Lrp1-mediated signaling during RVFV infection is unknown.
The development by our lab of an Lrp1f/fAlbcre model, which results in prolonged survival past hepatic disease,
validates cell specific KO of Lrp1 as a method to investigate Lrp1’s role in RVFV tropism and allows for the
further study of RVFV dissemination which was not previously possible. Macrophages and dendritic cells express
Lrp1, and I hypothesize that RVFV utilizes Lrp1 to enter and infect these cells, disseminate throughout the body,
and infect visceral organs and tissues. The proposed studies aim to investigate the expression levels of Lrp1 on
myeloid cells and associate this expression with susceptibility to RVFV. Cre/Lox knockout mice will be utilized to
specifically delete Lrp1 in certain myeloid cells and determine if RVFV utilizes macrophages and/or dendritic
cells to disseminate throughout the body. Signaling deficient constructs of Lrp1 will be generated to antagonize
the role of myeloid Lrp1 signaling in the host immune response to RVFV. Studying Lrp1 in the context of myeloid-
mediated viral dissemination and response may be the link needed to close the gap in the field in understanding
of pathogenic process. The results of these studies will significantly contribute to the field and our understanding
of RVFV pathogenesis and dissemination and inform the development of therapeutics targeting RVFV.

Public health relevance
PROJECT NARRATIVE Rift Valley Fever virus (RVFV), a pathogenic arbovirus with significant pandemic potential, relies on low density lipoprotein receptor-related protein 1 (Lrp1) for efficient cell entry and infection. I hypothesize that RVFV first infects myeloid cells at the site of infection in an Lrp1-dependent manner and then spreads to distant organs. This proposal will interrogate the role of myeloid Lrp1 in RVFV pathogenesis, dissemination, and the initiation of the host immune response.